Optimization of antimalarials targeting multiple life stages of the parasite

PROJECT SUMMARY/ABSTRACT [Parent grant]
The malaria parasite is one of the most deadly eukaryotic pathogens and more than 40% of the world's population is at risk
of contracting malaria. Due to growing resistance to currently available medications, there is a pressing medical need for
new drugs to prevent and treat malaria infection. This grant application focuses on the optimization of two novel
antimalarials (2a and (R)-3a) to target multiple life stages of the parasite that emerged from our previous work on the
Malaria Box compound MMV008138 that targets the apicoplast. These compounds were identified using a combination of
atomic property field-based virtual ligand screening (VLS) of a library of 5 million publicly available compounds and
synthetic chemistry campaigns. Although 2a and (R)-3a bear a structural resemblance to MMV008138 and kill asexual
blood-stages, their mechanism of action is independent of the apicoplast. In addition, whereas MMV008138 only affects
asexual blood-stages, 2a also kills Stage V gametocytes, and (R)-3a weakly kills Plasmodium berghei liver-stages. For each
of the two novel compound series, we will explore: i) structure activity relationships that control potency, cellular selectivity,
and efficacy; ii) structure property relationships that govern adsorption, distribution, metabolism, and excretion; and iii)
their potential mechanisms of action and resistance. The overarching goal of this project is to prioritize preclinical leads
having novel mechanism of action, high selectivity for Plasmodium versus the human host, and physicochemical properties
that are compatible with development of an orally available drug candidate. The two principal goals of this R01 proposal
are to: 1) structurally modify 2a (lead) and (R)-3a (hit) to optimize in vitro asexual blood-stage potencies in addition to
gametocitocydal and/or liver stage activities, drug-like properties, and pharmacokinetics, achieving in vivo P. berghei-
infected mice efficacy with a single oral dose ED90 ≤ 10 mg/kg for the 2a analogs (late lead) and an ED90 ≤ 40 mg/kg/day
with 1-3 oral doses for the (R)-3a series (early lead), and 2) identify the antimalarial mechanisms of action and resistance
of 2a and (R)-3a (or their more potent analogs) by chemoproteomic and resistance-selection approaches, respectively. The
ancillary goal of this proposal is to develop structure-activity relationships (SAR) for the P. falciparum gametocytocidal
potency and P. berghei liver-stage potency of these two series, and to determine consensus pharmacophores for multi-stage
activities (asexual blood-stage potencies plus gametocytocidal and/or liver-stage potencies). Efficacious compounds
identified in this way will thus be well-positioned for further preclinical development.

Public health relevance
PROJECT NARRATIVE Over one billion people are at risk of malaria infection every year and, unfortunately, the rapid development of resistance to all current antimalarials highlights the urgent need to develop new drugs with different mode of actions to overcome resistance. This work aims to optimize two novel, inexpensive and effective classes of antimalarials. Our studies will uncover how these novel antimalarials work revealing valuable biological information to aid the development of safer treatments to circumvent drug resistant toward malaria eradication.